Bispecific drug-conjugates for treating colorectal cancer

ABSTRACT:
Tumor heterogeneity and cancer stem cell (CSC) plasticity present a significant challenge to the effective
treatment of colorectal cancer (CRC). Several studies have established that Leucine-rich repeat containing, G
protein-coupled Receptor 5 (LGR5) marks CSCs and is highly upregulated in CRC. Plasticity of LGR5+ CSCs
has been shown to promote therapy resistance, tumor progression, and metastasis. CRC is also dependent on
the epidermal growth factor receptor (EGFR) and EGFR-targeted antibodies such as cetuximab (CTX) are
routinely used for the treatment of metastatic CRC. However, the clinical efficacy of EGFR-targeted treatment
has been limited to a subset of patients that do not harbor KRAS mutations. Antibody-drug conjugates (ADCs)
have experienced a recent surge in success within the past few years and several have now been approved for
solid tumor indications. The objective of this project is to develop a novel bispecific ADC (BsADC) directed
against LGR5 and EGFR and evaluate antitumor and antimetastatic efficacy in patient-derived models of CRC.
We propose leveraging the dual-targeting capabilities of an LGR5-EGFR bispecific antibody combined with the
ability of ADCs to exert potent drug effects irrespective of tumor mutational status, while minimizing systemic
toxicity. In Aim 1, we will generate a lead LGR5-EGFR BsADC with high potency and specificity in vitro. In Aim
2, we will evaluate tolerability and therapeutic efficacy of the lead LGR5-EGFR BsADC in subcutaneous and
orthotopic patient-derived tumor models of CRC. Results from this study will lead to the development of a unique
dual-targeted ADC and determine if it can overcome therapy resistance due to tumor heterogeneity and CSC
plasticity and prevent metastasis. Moreover, an LGR5-EGFR BsADC has the potential to treat other tumor types
that express high levels of either tumor antigen.

Public health relevance
PROJECT NARRATIVE: Drug resistance is a major cause of therapy failure in colorectal cancer patients largely due to tumor heterogeneity and the existence of cancer stem cells. The goal of this project is to generate novel bispecific antibody-drug conjugates (BsADCs) directed against two tumor targets that can eliminate cancer stem cells and overcome therapy resistance. BsADCs will be evaluated in patient-derived tumor models and a lead candidate will be identified for the future development of a new therapeutic to treat colorectal cancer.